Clonal analysis of cancer by mitochondrial DNA barcoding

Project Summary/Abstract
All tumors contain a mixture of different cell types. Within the malignant cell population, clonal evolution
leads to the emergence of clones with different genetic lesions, and various biological processes shape
the co-occurrence of different cell states that are characterized by specific transcriptional/epigenetic
landscapes. This heterogeneity underlies the persistence of small populations of tumor cells through
treatment, leading to disease recurrence, which is a major clinical challenge. To better understand clonal
structures and transcriptional/epigenetic states in primary human tumors, there is an unmet need for
technologies that comprehensively profile these modalities at single-cell resolution. The PI/PDs Peter
van Galen and Vijay Sankaran have pioneered the use of mitochondrial DNA (mtDNA) variants as
naturally occurring cell barcodes to reconstruct clonal relationships between cells, and demonstrate
simultaneous profiling of transcriptional (scRNA-seq) and epigenetic (scATAC-seq) cell states. As such,
they are uniquely positioned to realize the potential of these technologies to illuminate the complex tumor
ecosystem and identify vulnerabilities of different malignant cell types. The long-term goal of this
research is to guide new therapeutic approaches that can effectively eradicate heterogeneous tumor
cells. The overall objective is to establish enabling technologies that can be used across a wide range of
tumors to transform our understanding of cancer biology. Drs. Van Galen and Sankaran, supported by a
strong network of collaborators, will jointly work towards this objective through two specific aims: 1)
Advance and validate experimental methods to simultaneously dissect the transcriptome, epigenome,
and clonal structures in cancer and 2) Proof-of-principle profiling of acute myeloid leukemia clones at
diagnosis that subsequently drive recurrence. In the first Aim, the investigators will build on their recent
accomplishments to establish optimized and validated procedures for multi-omic analysis of primary
human cancer cells with clear performance measures. In the second Aim, paired diagnosis-relapse
samples from a well-defined cohort of acute myeloid leukemia patients will be analyzed to demonstrate
the simultaneous dissection of longitudinal patterns of clonal evolution with transcriptional/epigenetic cell
states - a key proof-of-principle for this technology. The approach is innovative by leveraging naturally
occurring mtDNA variants to layer clonal relationships onto current state-of-the-art assays for single-cell
analysis. The proposed research is significant because the successful completion of the project would
equip the scientific community with new tools for the comprehensive molecular/cellular characterization
of cancer. The expected output is a repeatable, reliable approach for single-cell analysis of primary
human cancer cells at three core modalities, yielding transcriptional, epigenetic, and clonal resolution.
This will be enabling for NCI-funded projects in a range of tumor systems.

Public health relevance
Project Narrative The proposed research is relevant to public health because tumor cell heterogeneity is at the core of therapy resistance and relapse, which remain major clinical challenges underlying poor outcomes for many cancer patients. This project is relevant to the NIH’s mission to seek fundamental knowledge to reduce illness because it will establish technologies for deep profiling of cancer cell clones that are responsible for disease progression. These technologies will be applicable across cancers and have a far-reaching impact.